Cancer Center Support Grant

UCSF Helen Diller Family Comprehensive Cancer Center: Summary/Abstract
The UCSF Helen Diller Family Comprehensive Cancer Center (HDFCCC) seeks to drive scientific discovery
and develop tailored interventions to improve cancer outcomes in the catchment area and beyond. This
mission, established through a unique strategic planning process, encompasses three Center-wide themes
that are integrated throughout the HDFCCC and will drive research into the next decade and thereafter.
Theme 1 (Impactful Discovery): Advance innovative basic, clinical, and population research, focused
on unique characteristics of the individual, disease, population, and community.
Theme 2 (Effective Translation): Translate research to define risk, emphasize prevention, optimize
diagnosis, tailor screening and treatment, and improve outcomes.
Theme 3 (Implementation and Dissemination): Reduce inequities in cancer awareness, prevention,
early detection and diagnosis, care, treatment, and patient-centered outcomes, through data-driven
science and community engagement.
The environment of the HDFCCC allows transdisciplinary connections between each theme, thus ensuring
continuity of support for research across the cancer continuum, from basic discovery science to population
science. This is accomplished through seven research programs supported by seven shared resources,
developmental funds, and robust clinical and administrative infrastructure. The HDFCCC defines three
Foundational Principles that are integrated throughout the Center and inform every aspect of cancer research:
Community Engagement; Education and Training; and Diversity, Equity, Inclusion, and Accessibility.
The HDFCCC builds on the richness of the basic biological insights and the extensive and exceptional clinical
research and facilities at UCSF, a university dedicated to health research. Moreover, its location in the San
Francisco Bay Area of Northern California allows the HDFCCC to leverage one of the most culturally diverse
populations and highly innovative and intellectually vibrant environments in the world. This environment helps
support the translational, transdisciplinary research of HDFCCC members in alignment with the Center’s
research mission of driving scientific discovery and developing tailored interventions to improve cancer
outcomes.

Public health relevance
UCSF Helen Diller Family Comprehensive Cancer Center: Narrative The UCSF Helen Diller Family Comprehensive Cancer Center (HDFCCC) seeks to drive scientific discovery and develop tailored interventions to improve cancer outcomes in the catchment area and beyond. This mission, established through a unique strategic planning process, encompasses three Center-wide themes that are integrated throughout the HDFCCC and will drive research into the next decade and thereafter: Impactful Discovery, Effective Translation, and Implementation and Dissemination.